Z-DNA and its role in RNA polymerase III transcriptional regulation

Abstract
DNA can adopt different conformations besides the typical B-form. One such alternative DNA structure
is Z-DNA which is characterized by unusual biophysical properties. Z-DNA is left handed, does not wrap the
histone octamer efficiently, and has two minor grooves. The Z-alpha domain, first discovered in ADAR1, specially
binds to the Z-DNA backbone in a sequence-independent manner. Although Z-DNA in the cytoplasm and Z-RNA
have both described roles in innate immunity, it is unclear what the function of nuclear Z-DNA might be. To map
Z-DNA in vivo, we used the Z-alpha ChIP-seq assay that captures regions of Z-DNA in vivo. We found that Z-
DNA is highly enriched at sites of RNA polymerase III. We suspected that a subunit of RNA pol-III might
recognize and induce Z-DNA formation. Indeed, POLR3F has cryptic structural homology to the Z-alpha domain
and POLR3F binds to 79% of all Z-DNA sites. Depletion of POLR3F shows that POLR3F is required for Z-DNA
formation at tRNA genes. POLR3F depletion also induces expression of nearby RNA polymerase II genes
indicating that tRNA transcription can interfere with neighboring gene expression. In this proposal, we will test
whether POLR3F has direct Z-DNA binding capacity using biochemical in vitro assays. Next, we will test through
separation of function mutants whether Z-DNA affinity of POLR3F is required for Z-DNA formation and tRNA
transcription by RNA pol-III. We will also evaluate the effect of RNA pol-III transcription on other genes genome
wide, as well as its effect on herpes virus transcription. Since missense mutations in POLR3F are found in
patients with innate immune defects, we will determine the impact of patient mutations on POLR3F Z-DNA
binding ability and function. Our integrated proposal will define physiological roles for Z-DNA in transcriptional
regulation using targeted studies of a previously unrecognized Z-DNA binding protein, POLR3F.

Public health relevance
Narrative Z-DNA is an alternative DNA structure that is implicated in genome instability and immunity. Our data show that Z-DNA localizes to RNA polymerase III sites such as tRNAs, 5s rRNA, and SINEs. We have discovered that an unrecognized component of the RNA polymerase III complex, a protein called POLR3F is a cryptic structural homologue of the Z-alpha domain (the best known Z-DNA binding protein) from ADAR1. POLR3F is required for Z-DNA formation at tRNAs. This study will help us understand the role of Z-DNA in both transcriptional regulation and innate immunity.